Decoding therapeutic, cross-presented tumor antigens in pancreatic cancer

Project Summary
Identifying therapeutically efficacious tumor antigens remains a significant challenge in cancer vaccine
development, as accurately predicting T cell responses from the bulk tumor immunopeptidome is difficult and
costly to validate. Dendritic cells (DCs) play a pivotal role in eliciting anti-tumor T cell immunity, but their unique
capacities to cross-present tumor antigens as a main driver of T cell infiltration in tumors have not been
thoroughly investigated. This proposal aims to uncover the differences between the tumor immunopeptidome
directly presented on cancer cells versus those cross-presented by DCs, and evaluate their contribution to T cell
infiltration in tumors. I developed a mass spectrometry-based, antigen discovery platform that empirically
identified peptides associated with MHC class I and II molecules on mouse DCs. This proposal will focus on
pancreatic cancer, in which cancer-intrinsic and extrinsic mechanisms foster an immunosuppressive
microenvironment and lead to T cell exclusion in the tumor. To determine whether immunosuppressive
mechanisms impair effector T cell infiltration in tumors by modulating tumor antigen landscape on DCs, I will use
in vitro and in vivo models combined with multi-omics approaches to decode DC antigen cross-presentation
capacities in mouse and human pancreatic cancer. In Aim 1, I will compare cancer cell- and DC-presenting tumor
immunopeptidomes in pancreatic cancer models with high- versus low-T cell infiltration, and test the hypothesis
that cancer-intrinsic factors downregulate DC cross-presentation capacities and result in poor T cell infiltration in
mouse pancreatic cancer (K99). In Aim 2, I will examine the impact of regulatory T cells (Tregs) on DC’s antigen
presentation capacities as extrinsic mechanisms and identify tumor antigens whose presentation on DCs is
enhanced following Treg ablation. I will then test the potential of Treg-downregulated antigens as cancer vaccine
targets to improve anti-tumor T cell immunity and enhance tumor control (K99-R00). Aim 3 will extend these
findings to human pancreatic cancer by examining the correlations between DC tumor antigen landscape and T
cell infiltration in patient-derived models. Collectively, these multipronged studies will improve our understanding
of cross-presented tumor antigens in driving immunosurveillance in pancreatic cancer and pave the way for
novel cancer vaccination strategies. This research will be supported by a multidisciplinary advisory team in tumor
immunobiology, including Drs. Michel DuPage (primary mentor, expert in cancer immunology and Treg biology),
Joshua Elias (immunopeptidomics and mass spectrometry expert), and Ellen Robey (T cell development and
antigen biology expert), and collaborators specializing in pancreatic cancer immunology. The exceptional
resources and collaborative environment at UC Berkeley will foster my transition to independence and support
my goal of advancing antigen discovery technologies for vaccine development against solid tumors.

Public health relevance
Project Narrative Identifying therapeutically efficacious tumor antigens remains a significant challenge in cancer vaccine development for pancreatic cancer. The essential role of antigen cross-presentation by dendritic cells to elicit anti-tumor T cell immunity highlights the clinical value of antigen discovery strategies to identify efficiently cross- presented tumor antigens. Here, I proposed a multipronged approach to evaluate how the tumor antigenic landscapes on dendritic cells are modulated by cancer-intrinsic and extrinsic mechanisms, and how this underly the heterogeneity of T cell infiltration in both human and mouse pancreatic cancer.